Emergency Granulopoiesis in Ventricular Remodeling

Myocardial infarction (MI) activates an acute immune response to instigate a wound-healing response. The
coincidence of these two processes suggests a relationship between the two. Activation of an acute response
involves the recruitment and activation of massive numbers of neutrophils. Studies in patients show that
increases in circulating neutrophils, even within the normal range, predict cardiovascular disease. Likewise, the
number of neutrophils in circulation at the time of MI correlates with the severity of ventricular dysfunction. Yet,
systemic depletion of neutrophils in mice prior to MI impairs wound healing response and results in ventricle
dilatation. Hence, there may be a balance between too many and too few neutrophils. Collectively, these
observations demonstrate a balance between the processes of inflammation and scar formation, and the extent
to which this balance is perturbed could drive pathology. We contend, however, that neutrophil abundance alone
is not the complete picture. Neutrophils are among the shortest-lived immune cells and are continuously
produced via granulopoiesis. Despite the inexorable nature of this process, acute increases in neutrophil
production in response to stress occur, and such demand-driven (or emergency) granulopoiesis may impact
neutrophil phenotype and function. Yet, the extent to which and how emergency granulopoiesis contributes to
functional diversity and scar formation is not known. Given this gap in knowledge related to how neutrophil
function is regulated after MI, we posit that the functional diversity—not simply total numbers—of neutrophils
dictates the extent to which the immune response promotes or antagonizes ventricular remodeling after MI.
furthermore, there is lack of clarity on how heart communicates to bone marrow to instigate emergency
granulopoiesis. This project will identify neutrophil-specific events involved in tissue inflammation and ventricular
remodeling, delinate the role of activated T cells in regulation of emergency granulopoiesis in bone marrow. The
main objectives of this proposal are to: i) delineate the role of T cells in activation of emergency granulopoiesis
after MI; ii) elucidate the impact of emergency granulopoiesis on neutrophil dynamics and phenotype; iii)
determine the role of neutrophil produced via emergency granulopoiesis on monocyte/macrophage dynamics
after MI; vi) test the extent to which neutrophil produced via emergency granulopoiesis contribute to ventricular
remodeling after MI. This project will create substantial knowledge about the mechanisms regulating emergency
granulopoiesis after MI. Moreover, we will establish how neutrophils emergency granulopoiesis neutrophils
regulate tissue inflammation and contribute to ventricular remodeling, thereby establishing fundamental,
innovative concepts at the nexus between inflammation and ventricular structure and function.

Public health relevance
The immune system is an important component of the body’s response to a heart attack. In this project, we will examine how the function of specific immune cells is regulated following a heart attack and how such cells contribute to the body’s response following a heart attack.